Flow Cytometry Core

Abstract
A key component of Phase III CoBRE funding for the Center for Cancer Biology Research (CCBR) is support of
the Flow Cytometry Core (Core B). This core, established in 2011 with the initiation of Phase I, is extensively
used by CCBR investigators, those at Sanford Research at large, investigators from regional institutions, and
recently by contractual users. The Core provides state-of-the-art equipment for flow cytometry, cell sorting, and
related sample preparation. The Flow Core staff provides a wide array of services in terms of instrumentation,
training, and experimental design. This allows investigators to obtain high quality data to support publications
and grant proposals. For Phase III, the Core presents a feasible plan for transitioning to independence. This plan
includes a fee-for-services schedule. Also, the Core will continue to expand its services through the acquisition
of state-of-the-art instrumentation and a growing user base, including additional clientele from regional
institutions and contractual arrangements. Already, the reputation of the Core's quality work and quick
turnaround has expanded regional and contractual usage. Based on this growth and substantial institutional
support through personnel salaries and equipment purchases and maintenance, self-sufficiency will be attained.
following Phase III support.